EFFECTS OF DYNORPHIN ON HEROIN ADDICTION

The goal of this proposal is to study the effects of the opioid peptide dynorphin in heroin abusers during acute abstinence. The proposed study is a phase I/II clinical trial aimed at obtaining preliminary information about the duration of action, safety and short-term efficacy of dynorphin in heroin addicts. The hypotheses to be tested are that dynorphin is safe, suppresses withdrawal, and reduces craving for heroin.